Analyzing the Hypersensitivity of MMR-deficient Colorectal Cancers to mTOR Inhibition and the Response of Cancer Stem Cells

Project Summary
Mutations in DNA mismatch repair (MMR) genes are causative in Lynch Syndrome (LS) and defective MMR
drives tumorigenesis in a significant proportion (15 - 20%) of sporadic colorectal cancers. The loss of MMR not
only increases genomic mutation rates, but also results in the resistance of tumors to conventional
chemotherapeutic agents. To study the how the loss of MMR causes colorectal tumorigenesis and affects the
response of intestinal tumors to treatment we developed a novel mouse line, termed VCMsh2Thu, carrying a
“humanized” TgfβRII allele (Thu) that is susceptible to coding frameshift mutations during MMR-driven intestinal
tumorigenesis. VCMsh2Thu is the first mouse model that develops colorectal cancers (CRCs) closely mimicking
the histopathologic features of CRCs in LS patients. In preliminary studies, we found that while rapamycin only
had a cytostatic effect on MMR-proficient (MMR+) CRC cell lines, it exerted a strong cytotoxic effect on MMR-
deficient (MMR-) CRC cell lines. Importantly, rapamycin treatment induced the rapid and persistent regression
of MMR(-) small and large intestinal tumors in our LS mouse models as well as of three MMR(-) patient-derived
CRC xenografts (PDXs), but not of MMR(+) CRC PDXs. Interestingly, mutations in oncogenes such as KRAS
or PI3KCA and tumor suppressor genes including APC or TRP53 so far did not affect the rapamycin response
in these PDX models. The striking response of MMR(-) tumors was due to the failure to efficiently repair
rapamycin-induced oxidative DNA damage, which resulted in autophagic cell death of differentiated tumor
cells. We also observed that MMR(-) tumors contain treatment resistant “cancer stem cell niches” consisting of
Lgr5+ and Bmi1+ cancer stem cells (CSCs) as well as Paneth cells that accumulate during rapamycin
treatment. Importantly, preliminary studies in MMR(-) CRC organoids showed that rapamycin is effectively
exported from CSCs and that inhibition of the P-glycoprotein transporter (P-gp) could provide a novel strategy
for their elimination. In addition, similar to CRCs in human patients, the CRCs in VCMsh2Thu mice are
characterized by increased expression of the stem cell marker Aldh1a3, suggesting an important role for
Aldh1a3+ CSCs in MMR- tumorigenesis. A novel Aldh1a3-Cre knock-in allele (AC) allows us to inactivate MMR
in Aldh1a3+ stem cells and study the effects on intestinal tumorigenesis and the rapamycin response. Based
on these findings, in this application we propose to study the effect of mTOR inhibition on the prevention and
treatment of CRCs in VCMsh2Thu preclinical mice and a panel of clinically well-annotated MMR(-) PDX models.
In addition, we will test a novel strategy involving P-gp inhibition for the elimination of CSCs in MMR(-) mouse
and human CRCs. Finally, we will perform an unbiased analysis of the CSC populations that persist during
rapamycin treatment in mouse and human MMR(-) CRCs by single cell RNAseq (scRNAseq) analysis.

Public health relevance
Narrative The DNA mismatch repair system (MMR) is essential for maintaining the integrity of mammalian genomes and defects in MMR are the cause of the most prevalent cancer syndrome, Lynch syndrome (LS) that is characterized by the development of cancers in the colon, endometrium ovary and other tissues as well as in significant number of sporadic colorectal cancers in humans. We are studying genetically modified mouse lines and human LS patient derived xenograft tumors with mutations in MMR genes to determine the ability of MMR in intestinal stem cells to suppress tumor formation. The goal of our studies is to provide a better understanding of the cellular and molecular mechanisms that underlie MMR-deficient colorectal tumorigenesis and to investigate novel strategies for the prevention and treatment of colorectal cancers with MMR defects.